Developmental Research Project Program

DEVELOPMENTAL RESEARCH PROJECT PROGRAM (DRPP) – SUMMARY
The Louisiana Biomedical Research Network (LBRN) Developmental Research Project Program
(DRPP) aims to bolster and broaden research endeavors at primarily undergraduate institutions
(PUIs) by funding peer-reviewed research projects. By enhancing research training for both
undergraduate and graduate students and empowering PUI faculty to engage in nationally
competitive biomedical research, DRPP contributes to a stronger pipeline of biomedical scientists
within the state. The program oversees several types of projects, including New Faculty Start-Up
Projects, Pilot Research Projects, Full Projects, and Developmental Translational Projects, each
tailored to different stages of research development and collaboration. Shared Instrumentation
Grants further augment research infrastructure at PUI campuses. Projects are selected based on
merit, evaluated quarterly by the Administrative Core (AC) and Executive Committee (EC) and
annually by the External Advisory Committee (EAC), Steering Committee (SC) and Mentoring
Chair. The DRPP's Specific Aims include establishing a robust portfolio of competitive research
projects across the INBRE Network, prioritizing shared equipment awards that benefit PUI
infrastructure. Additionally, the program aims to cultivate mentor-leaders who support DRPs in
tandem with PUI-funded investigators, ensuring mentorship aligns with specific research topics
and facilitating regular interactions between mentors and mentees. Evaluation and monitoring
mechanisms, including work-in-progress sessions and formal reviews during the annual LBRN
conference, ensure project accountability and progression. Projects that fail to demonstrate
significant progress may not advance to subsequent funding stages. Through these initiatives,
DRPP strives to fortify biomedical research capabilities at PUIs and foster a collaborative research
environment conducive to scientific advancement.